Predicting Heterogeneous Neurodevelopmental Outcomes in School-age Children with Early Caregiving Adversities

Project Summary
Children with severe Early Caregiving Adversities (ECAs) are the most vulnerable to psychopathology as a
result of prolonged neglect, abuse, and care disruptions that impact neurodevelopment. It is currently
estimated that addressing ECAs would lead to a 29.8% reduction in worldwide psychiatric illness. Existing
research, including findings from the original grant of this renewal, has demonstrated that there is a very strong
link between ECA exposures and increased risk for psychopathology and altered neurodevelopment at the
population level; and yet, given the heterogeneity in ECA populations, there is a critical gap in knowledge
regarding how ECAs increase any specific risks to an individual child. The proposed research addresses this
significant mental health problem by combining sophisitcated data-analysis methods that use experiential and
phenotypic heterogeneity together with longitudinal neuroimaging and behavioral assessments in school-age
children. This approach will increase precision when linking ECAs and child outcomes associated with the
Research Domain Criteria constructs of Negative Valence and Cognitive Control Systems (NVS/CCS). The
overarching goal of the present work is to create an explanatory model for the heterogeneous impact of ECAs
on neurodevelopmental trajectories of NVS/CCS. This project's premise is that children exposed to ECAs have
highly heterogeneous developmental histories as well as heterogeneous outcomes; therefore, prediction of
ECA outcomes requires cutting-edge, sophisticated data analytic methods. We hypothesize that data-driven
approaches will 1) more precisely define NVS/CCS outcomes for school-aged children with ECAs, and 2)
provide a more robust explanatory model for links between ECAs and NVS/CCS trajectories. Aim 1A subtypes
children with a history of ECAs based on 2.5-year developmental trajectories of NVS/CCS. 300 6-8 year old
children (250 sampled from previous institutional and foster care; 50 community comparisons) will provide
neuroimaging, behavioral, and self/caregiver reports every 15 months for 2.5 years. Biclustering methods will
be applied to the baseline and follow-up data to identify homogeneous NVS/CCS final outcome clusters of
children. Aim 1B develops an explanatory model to predict developmental trajectory subtypes for children with
ECAs, from early life profiles and brain/behavior phenotypes at the time of enrollment. Machine learning
methods applied to early life profiles, baseline NVS/CCS profiles, and sex, will predict developmental trajectory
subtypes. Aim 2 identifies adverse and protective life events during the 2.5-year assessment period that are
predictive of 2.5-year follow-up outcomes for children with ECAs. The inclusion of child-sex and current life-
events will identify potential divergence in pathways across middle childhood. This prospective design of
children exposed to various ECAs is designed to develop predictive models for ECA trajectory subtypes and
outcomes, which can inform our understanding of risk and protective factors in accord with the goals of
precision medicine.

Public health relevance
Project Narrative Children with severe Early Caregiving Adversities (ECAs) are the most vulnerable to psychopathology, and it is estimated that addressing ECAs would lead to a 29.8% reduction in worldwide psychiatric illness. Existing research has demonstrated that there is a very strong link between ECA exposures and increased risk for psychopathology and altered neurodevelopment at the population level; and yet, given the heterogeneity in ECA populations, there is a critical gap in knowledge regarding how ECAs increase any specific risks to an individual child. The proposed research addresses this significant mental health problem by combining longitudinal multimodal brain imaging and high- dimensional behavioral assessments in school-age children together with sophisticated data analytic techniques to increase precision when linking heterogeneous ECAs and child outcome with the goal of predicting mental health outcomes and identifying children who would benefit most from specific early interventions.